Heterogeneity in Toxicity of Oligomeric Amyloid Beta and Neuronal Resilience in Alzheimer Disease

PROJECT SUMMARY
This proposal presents a five-year research and career development plan for Andrew Stern, MD, PhD,
in the molecular basis of Alzheimer disease (AD), the leading cause of age-related cognitive failure worldwide.
Dr. Stern is an Instructor in cognitive and behavioral neurology at Brigham and Women’s Hospital (BWH).
The “amyloid cascade hypothesis” is the most studied theory of AD pathogenesis, positing that
abnormalities in the metabolism of the Aβ peptide lead to the two defining pathologic lesions of AD (amyloid
plaques of aggregated Aβ and neurofibrillary tangles of hyperphosphorylated tau), followed by loss of neurons.
There are two central problems with this hypothesis: some patients have abundant amyloid plaques but little
neuronal and cognitive loss; and clinical trials of antibodies that removed amyloid plaques have largely failed to
slow decline. This proposal addresses these problems by beginning two answer two questions: 1) What
biochemical and structural characteristics of the most toxic form of Aβ, soluble oligomers (oAβ), confer its
toxicity? Novel monoclonal antibodies will be used to test if calcium-associated and low molecular weight oAβ
subsets are correlated with tau abnormalities and dementia. CryoEM will allow structural characterization of
immunoaffinity purified calcium-associated oAβ. 2) Do genetic differences cause some patients’ neurons to be
more susceptible to toxic oAβ, and is oAβ from patients with high tau burden and dementia more toxic than
oAβ from patients without? Induced pluripotent stem cell-derived neurons (iNs) and post mortem brain tissue,
from patients with high amyloid pathology but varying tau and cognitive impairment will be compared using live
cell imaging. An important innovation is to use naturally-occurring, human brain-derived oAβ, which may be
more disease-relevant than synthetic oAβ. These experiments will help explain inconsistencies in our models
of AD pathogenesis. In the long term, the results may assist clinical trial and drug design.
The training goals of this proposal are for Dr. Stern to develop the necessary expertise to establish an
independent laboratory researching the molecular pathogenesis of AD under R01 funding. Over the five years,
Dr. Stern will acquire specific skills each with the one-on-one mentorship of an expert advisor: Aβ biochemistry
(Dr. Selkoe), iN models (Dr. Young-Pearse), protein conformational chemistry and structural biology (Dr. Vos),
neuropathology of neurodegeneration (Dr. Feany), and knowledge of AD clinical therapeutic development (Dr.
Sperling). Dr. Stern has developed a training plan consisting of one-on-one meetings, in-person courses, and
conferences. All mentors and advisors are renowned experts in their fields. Dr. Selkoe (primary mentor) is a
leading AD researcher with decades of mentorship experience, including successful K08 awardees. Dr. Young-
Pearse (co-mentor) is also a leading AD researcher, particularly in iN models of disease, and an accomplished
mentor. The BWH Department of Neurology is committed to supporting Dr. Stern through protected research
time (85%) and state-of-the-art facilities and equipment.

Public health relevance
PROJECT NARRATIVE Alzheimer disease (AD), the leading cause of dementia, is defined by the buildup of amyloid plaques in the brain made of Aβ protein and neurofibrillary tangles made of tau protein, but many people have high levels of amyloid plaque and no symptoms of dementia; furthermore, clinical trials of medications that showed removal of plaques mostly have not improved dementia symptoms. This proposal tests whether different people have different molecular types of Aβ in their brains, what they might look like under powerful microscopes, and whether different people’s neurons are differently affected by the most toxic forms of Aβ. This work has the potential to improve the design of new drugs for AD, improve clinical trials for existing AD investigative drugs, and identify new targets for future AD drug development.